The Causal Effect of Community-Based Treatment for Youths

DESCRIPTION (provided by applicant): Evidence for the effectiveness of community-based psychosocial treatments for adolescent substance use disorders is mixed, at best. Researchers'inability to detect strong or replicable treatment effects may result from their focus on the post-treatment effects of a single incident treatment episode. Recent conceptualizations of addiction and treatment suggest that these approaches which compare pre-post treatment effects may obscure some of treatment's most salient effects. For one, treatment effects should be expected to be greatest during treatment or concurrently. Second, from a treatment careers perspective, multiple treatment episodes over time are likely to lead to cumulative effects, which would be greater than those observed for any individual treatment episode. Finally, considerations of client heterogeneity suggest that effects of treatment may be greatest for a subgroup of patients (moderated effects), with such effects being obscured when combined with the smaller effects expected for other patients. With this renewal we propose to estimate the causal effects of treatment on adolescent outcomes by examining these three types of treatment effects which addiction theory suggests have an important role, but which have yet to be satisfactorily measured. To do so, we have assembled a large set of adolescent treatment outcomes data collected by RAND, the Center on Substance Abuse Treatment, and Chestnut Health Systems and which include background information, treatment outcomes and treatment histories for more than 10,000 adolescent treatment admissions. Using this rich data and a powerful new casual modeling technique for time-varying treatments, marginal structural models with inverse probability of treatment weighting, we propose four new aims: (1) Estimate the treatment effects of different levels of care on drug use and other outcomes observed while youths remain in treatment;(2) Estimate the causal effect of cumulative treatment experiences of different levels of care on 1-, 2-, and 6-year drug use and other outcomes;(3) Estimate how baseline and time-varying client characteristics moderate the concurrent and cumulative effects of level of care on recovery and substance use outcomes;and (4) Develop and evaluate statistical methods required for Aims 1 to 3, and compare findings to those produced using conventional treatment research methods. PUBLIC HEALTH RELEVANCE: The goal of this project is to determine causal effects of treatment services for adolescents on drug use and other outcomes using powerful, new causal modeling techniques that allow us to study the concurrent effects of treatment, the cumulative effects of multiple treatment episodes, and differential effects for subgroups of clients. To accomplish this objective, we will use a large set of adolescent treatment outcomes data that has been collected by RAND, the Center on Substance Abuse Treatment, and Chestnut Health Systems, which includes treatment outcomes and treatment histories for more than 15,000 adolescent treatment admissions. By pursuing this research, we will improve the measurement and understanding of the effects of treatment and develop and disseminate more relevant and robust causal modeling approaches to substance abuse treatment services research than are currently standard in the field, thereby addressing key goals set by the 2004 Blue Ribbon Commission Task Force on Health Services Research at the National Institute on Drug Abuse.

Public health relevance
Project Narrative The goal of this project is to determine causal effects of treatment services for adolescents on drug use and other outcomes using powerful, new causal modeling techniques that allow us to study the concurrent effects of treatment, the cumulative effects of multiple treatment episodes, and differential effects for subgroups of clients. To accomplish this objective, we will use a large set of adolescent treatment outcomes data that has been collected by RAND, the Center on Substance Abuse Treatment, and Chestnut Health Systems, which includes treatment outcomes and treatment histories for more than 15,000 adolescent treatment admissions. By pursuing this research, we will improve the measurement and understanding of the effects of treatment and develop and disseminate more relevant and robust causal modeling approaches to substance abuse treatment services research than are currently standard in the field, thereby addressing key goals set by the 2004 Blue Ribbon Commission Task Force on Health Services Research at the National Institute on Drug Abuse.